Cardiac protective mechanisms of melanocortin system activation

PROJECT SUMMARY/ABSTRACT
Over 1.5 million Americans suffer from myocardial infarction (MI) each year, and about 25% of these patients
develop severe cardiac dysfunction including congestive heart failure (HF), which has a high 5-year mortality
rate of ~50%. Current therapies following MI have limited success in attenuating cardiac dysfunction and slowing
HF progression. Thus, there is a critical need for novel, more effective therapies that protect the heart, improve
its function, and slow/halt progression of cardiac dysfunction. We recently demonstrated that activation of the
brain leptin-melanocortin system pathway greatly improves cardiomyocyte energy metabolism and contractility,
preserves cardiac function, and prevents progression of HF following MI induced by ligation of the left anterior
descending coronary artery. We observed that intracerebroventricular (ICV) infusion of leptin for 4 weeks, at a
low dose that did not alter blood leptin concentration, restored ejection fraction, cardiac output, left ventricle (LV)
muscle strain and left atrium/aorta diameter ratio almost all the way back to normal baseline values, and
preliminary data suggest that other measures of cardiac function such as +dP/dtmax and exercise capacity were
also markedly improved. We also observed that these cardiac protective effects are absent in melanocortin 4
receptor (MC4R) deficient rats and that activation of brain MC4R using synthetic agonists infused into the
cerebral ventricles protected the heart against progressive cardiac dysfunction after MI in a similar fashion
compared to leptin treatment. Our preliminary data also indicate that activation of the CNS leptin-MC4R pathway
increases sirtuin-3 (SIRT3) expression, mitochondrial biogenesis and substrate oxidation (i.e., glucose and fatty
acid oxidation), and improves cardiomyocyte contractility in non-infarcted regions of the LV, including areas at
risk but still viable. The central hypothesis of this proposal is that activation of the brain melanocortin system
improves cardiac function and prevents progression of HF after MI, increases myocardium
mitochondrial biogenesis and SIRT3 levels, enhances substrate oxidation, and improves energy
production and cardiomyocyte contractility in healthy portions of the heart. We also propose that these
beneficial effects of the melanocortin system on the heart require MC4R activation in PVN and/or
DMV/NTS/IML, and that MC4R agonists that cross the blood-brain barrier (e.g. setmelanotide) and can
be administered systemically will be effective to provide cardioprotective even in the setting of obesity.
We will use state-of-the-art chronic in vivo protocols with high-resolution ultrasound techniques for imaging
cardiac function (including 4D-strain echocardiographic imaging technology) in genetically engineered animal
models combined with ex vivo and in vitro preparations for detailed measurements of cardiac muscle function,
morphology, energy metabolism and contractility to test our hypotheses. The outcomes from this study could
lead to novel and more effective therapeutic approaches for MI and HF, and will provide a new target for MC4R
agonists which are currently being used to treat rare forms of genetic obesity in humans.

Public health relevance
PROJECT NARRATIVE Cardiovascular diseases are the leading causes of mortality and morbidity in the United States and worldwide. Current therapies for heart failure after myocardial infarction offer only limited benefit and new, more effective treatments that can slow/halt disease progression and improve heart function are desperately needed. The primary focus of this proposal is to test a novel therapeutic approach for preventing progression of heart failure after myocardial infarction by activating brain melanocortin 4 receptors and to unravel the molecular/cellular mechanisms involved.